Building a Contextually Triggered Just-in-Time Intervention for Opioid UseDisorder: Stakeholder Evaluation and User Centered Design

Abstract
The opioid epidemic represents a major public health crisis in the U.S. Although medications
such as buprenorphine are the current gold standard treatment for individuals diagnosed with
opioid use disorder (OUD), a significant proportion of patients return to illicit opioid use and/or
discontinue treatment prematurely. Moreover, the co-occurrence of a psychiatric condition is
one important contributor to poor treatment outcomes. Recognizing and responding adaptively
to substance-related and personal cues that can trigger both craving and substance use
behaviors is a crucial behavioral strategy for managing or overcoming OUD. Digital
technologies, especially personal smartphones, represent promising platforms to transcend
traditional barriers to care, and smartphone sensors can be used to objectively, yet passively,
assess aspects of cue exposure (e.g., geographic proximity to personalized locations where an
individual typically obtains or uses opiates, psychological distress) which can be leveraged to
deploy tailored, just-in-time supportive interventions to promote recovery and psychological well-
being. The focus of this application – the Vira Mobile App - is a digitally enhanced behavior
change platform that has primarily been used in the management of mental health symptoms.
Given the relevance of both substance-related and personal cues in the maintenance and
relapse of addictive behaviors in OUD, one promising approach to the development of just-in-
time adaptive interventions is to use mobile sensing to anticipate and avoid exposure to cues,
and to facilitate the use of coping skills in the presence of cues. Therefore, in this Phase 1 SBIR
application, we will conduct technical development and formative, user centered research on
extending the capabilities of the Vira platform to provide just-in-time intervention for two types of
cues that play a role in the maintenance and relapse in OUD – 1) personalized geographic
locations that are associated with obtaining and using drugs, and 2) emotional distress. As
such, the aims of this Phase 1 SBIR application are to develop, adapt, and refine the Vira
platform for use as a scalable, adjunctive treatment for OUD.

Public health relevance
NARRATIVE The opioid epidemic represents a major public health crisis in the U.S, and access to effective treatment is a key challenge. In this project we will conduct interviews with people experiencing opioid use disorders (OUD) and the practitioners who work with them in order to adapt and extend the capabilities of an established digital behavior change platform so it can provide real time interventions that will help people recover from OUD and prevent relapse. This project will allow us to make critical adjustments to the platform to prepare it for clinical trials as an adjunct to treatment for OUD.